A new approach to understanding cognitive disabilities in Down syndrome

Project Summary
Down syndrome (DS), caused by a third copy of the human chromosome 21 (Hsa21), occurs in about 1 of every
700 births in the U.S. DS is the leading cause of genetically-defined intellectual disability, with a serious impact
on public health. Several neurodevelopmental hypotheses for cognitive disabilities in DS have been proposed,
but one of the most compelling is the GABAergic hypothesis for DS, which postulates that alterations in GABA
signaling in early brain development may contribute to its neuropathology. Recent studies have found that a
mouse model of DS, Dp(16)1Yey/+ mice (hereafter called Dp16), shows a similar deficit seen in patients with
DS, including reduced cortical GABAergic interneurons. Despite the importance of prefrontal cortex (PFC) in
higher cognitive processes and the observed functional impairments in PFC of people with DS, little is known
about the neurobiological mechanisms that mediate the detrimental effects of altered GABAergic neuronal
activity on PFC development and cognition in DS. In order to understand how these impairments arise, it is
necessary to first understand the basic cellular and synaptic mechanisms of GABAergic regulation of brain
function and how they are altered in the DS brain. In this R21 proposal, we utilize a novel combination of tools
including two-photon microscopy, electrophysiology, chemogenetics, and in vivo pharmacological manipulation
to test our central hypothesis that decreased inhibitory neuronal activity weakens GABAergic synapses and
induces abnormal excitatory synapse maturation via heterosynaptic crosstalk in the PFC of Dp16. Guided by our
strong preliminary data, we will examine this hypothesis in two specific aims: 1) Determine whether Dp16 mice
exhibit structural and functional alterations of inhibitory and excitatory synapses on layer 2/3 pyramidal neurons
in the PFC. 2) Determine the role of inhibitory activity in excitatory synapse maturation in the PFC of Dp16.
Results from this exploratory study will further our understanding of the unique and detailed mechanisms by
which GABA regulates brain development, with critical relevance to cellular underpinnings of PFC dysfunction
and intellectual disability in DS. We expect that our results will highlight new avenues into the investigation of
the pathophysiology underlying DS resulting from early perturbation of GABA signaling.

Public health relevance
Narrative Down syndrome (DS), which occurs in about 1 of every 700 births in the U.S., is the leading cause of genetically- defined intellectual disability, with a serious impact on public health. The prefrontal cortex (PFC), a major cortical area associated with higher cognitive processes, is known to be disrupted in people with DS. Defining how PFC function is altered in DS mouse model is a key first step to understanding the human condition of DS. An enhanced understanding of neurobiological mechanisms that mediate intellectual disability in DS could have substantial implications for improving the outcomes of people with DS.